Hypothalamic oxytocin influence on extended amygdala CRF neurons in alcohol dependence

PROJECT SUMMARY/ABSTRACT
Alcohol Use Disorder (AUD) is a chronic relapsing disorder characterized by compulsive seeking and
consumption of alcohol, the result of a transition from recreational use to misuse to AUD. Most AUD sufferers
do not receive treatment, and current medications do not work for all patients, highlighting the need for new
therapeutics. AUD induces heightened activity of brain stress systems, resulting in the negative affective state
associated with withdrawal. The neuropeptide oxytocin (OT) is anti-stress, and systemic administration of OT
decreases withdrawal symptom severity and drinking in people with AUD. The central amygdala (CeA) and bed
nucleus of the stria terminalis (BNST) are two brain regions considered to be hubs for stress processing, and
the role of pro- and anti-stress neuropeptides in these brain regions are critical for the development of AUD.
Synaptic activity in the CeA and BNST is sensitive to acute alcohol, and plays a critical role in the behavioral
effects of ethanol consumption. The CeA and BNST are rich in neuropeptides and their receptors, including
corticotropin releasing factor (CRF) and OT, and ethanol’s effects on synaptic signaling in these regions may be
modulated by neuropeptide activity. CRF is involved in the heightened stress and anxiety associated with AUD
during withdrawal, and blocking CRF activity in the CeA and BNST can reduce alcohol drinking. Thus, the
balance between anti- and pro-stress signaling is likely perturbed during the transition to AUD, characterized by
an overactive CRF system. OT producing neurons in the paraventricular and supraoptic nuclei of the
hypothalamus project to both the CeA and BNST, to specific subdivisions that contain CRF neurons. Thus, OT
may act directly on CRF neurons of the CeA and BNST to decrease withdrawal severity and alcohol drinking.
For this Diversity Supplement, Emaya Moss (candidate), will contribute to experiments within all Aims of the
parent grant. Initially, Emaya will receive training from the PI in the techniques necessary for this research,
including ex vivo slice whole-cell patch clamp electrophysiology, molecular biology techniques, the chronic
intermittent ethanol (CIE) vapor dependence model, stereotaxic surgeries, chemogenetics, and alcohol drinking
behavior. Once Emaya has learned a technique, she will begin to work on experiments incorporating that
technique while training in additional techniques. As such, she will perform research into the connectivity of OT
and CRF neurons, intrinsic properties and synaptic function of these neurons, how these circuits are disrupted
by CIE vapor dependence, how these circuits contribute to alcohol drinking, and any sex differences within these
measures. In addition, throughout the remaining parent grant period, Emaya will finish her graduate coursework,
attend weekly journal clubs and lab meetings, and will also have weekly mentorship meetings with the PI focused
on publications, grants, awards, conference presentations, workshops, etc. to ensure she is prepared to take on
the next steps toward a career as an independent researcher in academia.

Public health relevance
Project Narrative Alcohol use disorder is a major burden on public health that is characterized by excessive pro-stress brain signaling that drives compulsive alcohol drinking. Oxytocin is an anti-stress brain peptide that blocks compulsive alcohol drinking in alcohol dependence, but the exact neural mechanism underlying this oxytocin effect is not yet known. This project will examine the neural circuits and mechanism by which oxytocin opposes pro-stress and pro-drinking effects and may reveal new targets for the development of medications to treat Alcohol Use Disorder.